Unraveling FcepsilonRI-independent regulation of mast cell functions by the ITCH ubiquitin ligase

PROJECT SUMMARY
Mast cells (MC) are innate immune cells that occupy a unique niche in tissues in which they reside as long-lived
perpetrators of immunoglobulin E (IgE)-mediated hypersensitivity and many other inflammatory responses. We
have shown that MC initiate skin and lung inflammation through the rapid release of inflammatory mediators,
including cell-attracting chemokines. This occurs, in part, in a FcεRI-independent manner through ligation of
receptors (R) for a bioactive signaling lipid, sphingosine-1-phosphate (S1P), and for lipopolysaccharide (LPS),
an endotoxin present in most environmental antigens (Ag) penetrating the body. Engagement of MC-stimulating
R signalosomes encompasses kinase phosphorylation/activation, ultimately leading to transcription factor signal
transducer and activator of transcription 3 (STAT3) and nuclear factor kappa light chain enhancer of activated B
cells (NF-κB) activation, linked to chemokine release. Little is known about the regulatory pathways halting MC
activation to restore homeostasis. One of the mechanisms limiting inflammation and MC functions is through
ubiquitination. E3 ubiquitin ligases attach ubiquitin chains to protein substrates for rapid removal of unwanted or
damaged proteins and have been described as negative regulators of IgE-mediated signaling and subsequent
mediator release by MC. Deficiency of the E3 ubiquitin ligase ITCH results in systemic inflammation of the
mucosal surfaces, such as skin and lungs. Similar findings are described in human patients, including clinical
manifestations of atopy. Thus, there is an unmet need to understand how ITCH regulates inflammation and MC
biology. Our preliminary data show that primary MC express ITCH, which is predicted to interact with several
MC-restricted enzymes. Moreover, ITCH negatively regulates inflammation by controlling the ubiquitin-editing
enzyme TNF Alpha Induced Protein 3 (Tnfaip3/A20) function, thus NF-κB activation. ITCH is also predicted to
interact with Bruton’s tyrosine kinase (BTK), an enzyme involved in MC activation that we also found is essential
to STAT3 activation downstream of S1P signaling in MC (our preliminary data). The objectives of this application
are to determine how ITCH affects MC intrinsic function in vitro and in vivo, and to identify ITCH-regulated targets
in these pathways using primary MC. We anticipate that our proposed studies will provide novel mechanistic
data delineating how ITCH, an E3 ubiquitin ligase, can regulate signaling mechanisms driving skin and lung
inflammation and MC functions. These mechanistic insights will identify an actionable inflammation-enabling
molecular target in ITCH as a regulator of MC reactivity, with the potential to prevent the onset of inflammation
and progress to a diseased state.

Public health relevance
PROJECT NARRATIVE Little is known about the regulatory pathways halting mast cell (MC) activation. We propose that ITCH, an E3 ubiquitin ligase, controls local MC activation through repression of S1PR2 and/or TLR4 signaling by targeting downstream activation of BTK kinase and STAT3 and/or NF-kB transcription factors, linked to cell-attracting chemokine production. Newly identifying ITCH as a negative regulator of MC activating pathways will control inflammation and prevent progression to a diseased state of skin and lungs.